Translation of Evolved Oncolytic Virotherapy Product for Colorectal Cancer Treatment

Project Summary/Abstract
Colorectal cancer is diagnosed in an estimated 1.93 million new patients and causes nearly 1 million deaths
per year worldwide, numbers that are unfortunately predicted to rise. Immunotherapies, including CAR-T cells
(which involve T-cell targeting of a tumor-associated antigen) and checkpoint inhibitors (which stimulate
adaptive immune responses by blocking signals that inhibit immune cells), have substantially advanced
oncology but suffer low response rates in solid tumors that suppress immune responses. Oncolytic
virotherapies, viral vectors engineered to selectively replicate within and deliver genetic cargo to tumors, are
an immunotherapeutic modality that can combine and elevate the advantages of both CAR-T and checkpoint
inhibitor therapies by mediating multi-antigen targeting of immune cells to tumors and expression of multiple
cargoes to overcome immunosuppressive tumor microenvironments. However, oncolytic virotherapies are
challenged by limited delivery efficiency, including poor biodistribution to tumors and limited dissemination of
therapeutic cargo within and among metastasized sites.
To overcome these challenges, Vivere Oncotherapies, Inc. is advancing its evolved oncolytic virotherapy
product, OV-151, to the clinic. OV-151 confers improved delivery, lowered tumor burden, and increased
survival for in vivo murine models of colorectal cancer. Here, we propose three aims to advance OV-151 as
a clinical therapeutic candidate: 1) characterize the delivery properties of our lead clinical vector to tumors in
vitro and in vivo, 2) characterize and optimize cargo to deliver using our vector, and 3) develop an inducible
promoter to synergize potent immunostimulatory cargo expression with improved tumor-specific delivery
efficiency. Successful completion of these aims—which include precursor experiments toward optimizing
manufacturing and purification processes—will yield a strong basis for future execution of IND-enabling
studies, submission of a Phase II SBIR application, and preparation for an FDA INTERACT meeting.
Throughout this process, the Small Business Transition Fellow applicant, Dr. Adam Schieferecke, PhD, will be
supported in his work daily by his fellow full-time Vivere personnel member (Dr. Hyuncheol Lee, DVM, PhD),
weekly by his highly accomplished business and technical mentors (Drs. Melissa Kotterman and David
Schaffer, respectively) who have also committed to completing the NIH I-Corps program with him, bi-weekly
with his scientific advisory board mentors (Drs. Phung Gip and David Raulet), and bi-quarterly with his
investor and physician KOL (Drs. Tony Kulesa and Brad Stohr, MD, PhD, respectively).

Public health relevance
Project Narrative Every year, colorectal cancer kills over 53,000 people in the U.S. and nearly 1,000,000 people worldwide. Oncolytic virotherapies represent a promising approach to stimulate the immune system to infiltrate and recognize tumors but face hurdles toward reaching all tumor sites. Development of Vivere Oncotherapies, Inc.’s next-generation vector candidate, OV-151, will help overcome prior delivery challenges for colorectal cancers to effectively treat a significant patient population in need.